Leveraging in vivo protein tracking to identify novel immune markers associated with obesity driven disease

PROJECT SUMMARY.
To date, biochemical tools to study secreted proteins’ origins and destinations leading to the discovery of new
biomarkers associated with disease are underdeveloped. Deciphering interorgan communication pathways will
provide insights into key modulators of obesity driven inflammation. Interorgan dysfunction from
overconsumption, hence overstimulation of key metabolic pathways, has a significant impact on the development
of metabolic diseases, such as Type II Diabetes, cardiovascular disease, liver disease, and cancer. Specifically,
disrupting the interaction between the intestine and adipose tissue plays a crucial role in the development of
complications of obesity. Therefore, uncovering intestinal secreted proteins trafficked to adipose tissue can in
the future lead to the development of druggable targets that may attenuate the progression of obesity related
metabolic diseases. The objective of this proposal is to utilize novel tools to study the interorgan communication
pathway between the intestine and adipose tissue immune cells. We have developed a Cre-inducible
endogenous biotin-ligase BirA*G3 affinity tracking system expressed in the mouse intestine, with the capability
of biotin-tagging proteins sent through the endoplasmic reticulum of intestinal epithelial cells. After Cre-induction,
the addition of free-biotin induces rapid labeling of the intestinal epithelium, and of all secreted proteins. Utilizing
streptavidin affinity enrichment, we capture the proteins trafficked to our target organ and employ tandem mass-
tag (TMT) quantitative mass spectrometry proteomics to identify the low-abundance trafficked proteins, as well
as their origins and destinations. Using this approach, we identified PlexinB2 which is secreted from intestine to
regulate subcutaneous white adipose tissue lipolysis and systemic metabolism. I hypothesize that the intestines
regulate adipose tissue remodeling and inflammation by secreting signals including PlexinB2 to distinct immune
cells populations in response to diet induced inflammation. Specifically, in Aim 1, I will elicit novel proteins
trafficked from the intestines to adipose tissue immune cells, in mice. I will determine and validate the intestinally
secreted proteins targeting adipose tissue immune cells during a high fat, fructose, and cholesterol diet which
induces obesity. Then, in Aim 2, I will define the impact of enriched intestinal proteins on immune cell function. I
will determine the effect of these identified secreted proteins, including PlexinB2, on macrophages, dendritic
cells, T-cells and B-cells in vitro. Finally, I will demonstrate the biological significance of discovered proteins
using in vivo models of overexpression as well as the effects our validated Plexin-B2 knock-out mouse has on
immune cell function in vivo. Advised by Dr. Ilia Droujinine, co-advised by Dr. Enrique Saez, and in collaboration
with Drs. Ben Cravatt, Lindsey Miles, and Howard Hang, my multidisciplinary training will enable me to advance
proteomic tools to study organ-to-organ communication, and during its course to become an expert and an
independent investigator in the field of metabolic disease.

Public health relevance
PROJECT NARRATIVE. The intestinal epithelium, responsible for transmitting signals from nutrient and toxin intake, plays a piv- otal role in interorgan communication during the development of obesity. In this grant, we will determine how obesity impacts intestinal protein secretion, and how adipose tissue immune cells are affected by these intestine-secreted proteins during the development of obesity. Characterization of these secreted biomarkers will contribute to the development of targeted therapeutics, advancing medical practices and enhancing overall health for individuals affected by obesity-related maladies.